Sex, Hormones and Identity affect Nociceptive Expression (SHINE)

Sex, Hormones and Identity affect Nociceptive Expression Observed in Non-binary adults (SHINE ON)
Project Summary
In the clinical population, women are more likely to report chronic pain and greater pain sensitivity than men
and this difference has traditionally been reported as a “sex” difference. Too commonly, many conflate “sex”
and “gender”, though these terms are not the same, nor are they always congruent. Our previous work showed
that transgender women (TW) and cis women (CW) reported similar pain sensitivity that was different from cis
men (CM), suggesting that gender identity was more important than sex assigned at birth. Whereas our current
project (1R01-NR019417-01) seeks to explore pain sensitivity and immune cell function in cis and trans men
and women (CM, CW, TM, TW), no pain-related study to date has included non-binary adults (NB). The current
proposal seeks to add 40 NB adults [20 assigned male at birth (AMAB); 20 assigned female at birth, (AFAB)] to
the ongoing parent project to investigate the impact of this gender identity category on pain sensitivity and
immune cell function. NB adults often face additional stigma and discrimination and are at risk for poor mental
health outcomes, making it imperative to include this group in the parent project. The proposed project builds
on the ongoing SHINE project (1R01-NR019417-01) in response to the Notice of Special Interest (NOSI: NOT-
OD-22-032) and is directly in line with the 2022-2026 NINR Strategic Plan framework and priorities.

Public health relevance
Sex, Hormones and Identity affect Nociceptive Expression Observed in Non-binary adults (SHINE ON) Project Narrative This project addresses health equity through investigation of pain sensitivity and immune cell function via inclusion of a traditionally understudied at-risk gender minority group – non-binary adults. The proposed project builds on the ongoing SHINE project (1R01-NR019417-01) in response to the Notice of Special Interest (NOSI: NOT-OD-22-032) and is directly in line with the 2022-2026 NINR Strategic Plan framework and priorities. This work will significantly add to our body of knowledge and the ways in which sex assigned at birth, gender identity and hormones affect pain and immune function in adults, with a special emphasis on sexual and gender minority groups.